Investigating astrocytic RIPK3 as a driver of protective neuroinflammation during viral encephalitis

Abstract
Astrocytes are versatile glial cells that regulate diverse processes in the central nervous system (CNS).
Roles for astrocytes during disease are complex and include both protective and pathologic functions. Recently,
distinct astrocyte activation states have been described, though the molecular mechanisms that govern astrocyte
polarization during neurotropic viral infection are not well understood. Here, we propose that receptor-interacting
protein kinase-3 (RIPK3) is a previously unappreciated driver of inflammatory astrocyte activation during viral
infection of the CNS. While roles for RIPK3 in programmed cell death have been extensively characterized, our
published work has described pleiotropic, cell death-independent functions for this pathway in the coordination
of protective neuroinflammation during viral encephalitis. In preliminary studies, we now show that RIPK3
signaling in astrocytes is required for survival and virologic control following challenge with Zika virus, an
emerging neurotropic pathogen of global concern. Using a combination of novel mouse genetic tools, we will
elucidate roles for RIPK3 signaling in astrocytes by 1) Defining profiles of expression, activation, and antiviral
function for astrocytic RIPK3; 2) Determining roles for astrocytic RIPK3 signaling in coordinating
neuroinflammation; and 3) Defining key substrates and transcriptional outputs of RIPK3 signaling in astrocytes.
Together, our studies promise to identify new molecular mechanisms governing protective neuroimmune function
during viral encephalitis.

Public health relevance
Project Narrative Neurotropic flaviviruses, including Zika virus, are a growing threat to global health. Despite the increasing burden of neurologic injury and cognitive impairment associated with flavivirus encephalitis, no disease-specific therapies for these infections exist. Here, we aim to identify new molecular mechanisms that promote protective neuroimmune function during Zika virus infection of the brain. These findings would uncover much-needed new molecular targets for the development of therapeutic and intervention strategies.